Functional synergistic perilaryngeal muscle network using synchronized multi-sensor surface electromyography to improve diagnosis and treatment of voice disorders

Project Summary/Abstract
There is a significant gap in understanding and quantifying vocal hyperfunction, a common symptom in patients
with phonotraumatic and nonphonotraumatic dysphonia. Vocal hyperfunction is characterized by excessive per-
ilaryngeal muscle activity and often leads to muscle pain, increased vocal effort and strain, and vocal fatigue.
Current diagnostic methods rely heavily on subjective patient reports and unvalidated clinical evaluations, mak-
ing it challenging for clinicians to accurately diagnose and track treatment outcomes, which ultimately impacts
the quality of care provided to these patients. The proposed research aims to address this gap by developing a
novel biomarker of vocal hyperfunction: functional synergistic perilaryngeal muscle network connectivity using
synchronized multisensor surface electromyography. This innovative approach will create a new spectrotempo-
ral synergistic scan to quantify the complex coordination (and discoordination) of perilaryngeal muscles during
typical and dysphonic voicing. This method is expected to provide a more reliable and objective measure of vo-
cal hyperfunction. The central hypothesis is that vocal hyperfunction is characterized by disturbances in mus-
cle coordination during voicing, which can be measured using the functional synergistic perilaryngeal muscle
network connectivity scans. This hypothesis will be tested in three aims. Aim 1: Distinguish patterns of peri-
laryngeal muscle discoordination across dysphonic conditions. Aim 2: Quantify the synergistic perilaryngeal
neuromuscular response to standard treatment. Aim 3: Determine the synergistic perilaryngeal neuromuscular
response to vocal demand. These specific aims will improve understanding of the variable pathophysiology of
vocal hyperfunction in different types of dysphonia. The proposed research is significant because it will shift our
understanding of voice disorders by providing an objective biomarker of vocal hyperfunction pathophysiology.
This approach, characterized by its objectivity, reliability, repeatability, and specificity, is crucial for accurate di-
agnosis. This will, in turn, enhance the delivery of effective care, promote early diagnosis, reduce instances of
misdiagnosis, and contribute to the advancement towards precision medicine. Objective measurement of vo-
cal hyperfunction can also help navigate treatment plans by tracking neurophysiological responses, enabling
informed therapy and dosing. Ultimately, the knowledge gained from this research has the potential to inform
future clinical trials assessing the predictive ability of this biomarker for treatment responses for vocal hyperfunc-
tion. This could lead to a paradigm shift in the management of vocal hyperfunction-related dysphonia, paving
the way for more targeted and effective treatments

Public health relevance
Project Narrative The proposed research is relevant to public health as it aims to develop an objective biomarker for vocal hyper- function, a common symptom in patients with dysphonia. This development is expected to improve diagnosis, treatment outcomes, and quality of life for individuals suffering with voice disorders. Therefore, the proposed re- search aligns with the NIH’s mission to foster innovations that improve health, extend healthy life, and reduce the burdens of illness and disability.